Explore the role of a new chemokine to alleviate postoperative pain

Project summary/Abstract.
Chronic postoperative pain affects millions of Americans every year. Postoperative pain
management is a clinical challenge; 10-20% of patients do not receive adequate pain relief
and opioid-based medications may lead to opioid dependence. The immune system plays
a critical role in the development of pain. Targeting peripheral immune mediators
represents an attractive therapeutic strategy without the disadvantage of central nervous
system (CNS)-associated side effects. Our preliminary data revealed that blocking CCL12
alleviated postoperative pain and conversely administration of CCL12 induced
nociception. CCL12 has never been investigated in preclinical pain research. Its receptor
CCR2 is expressed in sensory neurons and immune cells. We hypothesize that targeting
CCL12 is effective and safe to reduce pain after surgery. Our first specific aim will test that
neutralizing CCL12 is antinociceptive in two clinically relevant postoperative pain models
and that neutralizing CCL12 does not affect morphine analgesia and reward. Our second
specific aim will explore the mechanisms by which CCL12 induces nociception. More
specifically, we will investigate the cellular target of CCL12. Success in this project could
identify CCL12 as a promising target for managing surgical pain, offering a safer
alternative to opioids. Understanding how CCL12 influences pain mechanisms would
advance neuroimmunology and potentially lead to more effective pain treatments. Unlike
previous approaches targeting CCR2, which yielded mixed results, focusing on CCL12
may offer a more precise solution. Local administration of CCL12-neutralizing antibodies
could provide targeted pain relief without central nervous system side effects, presenting
a significant advancement in peri- and postoperative pain management.

Public health relevance
Narrative. More than 4 million of Americans develop persistent pain after surgery causing discomfort, distress, and disability. Therefore, efficient and safe novel pain medicines are urgently needed. We suggest that a molecule called CCL12, which hasn't been studied in pain research before, could be a promising target for reducing long-lasting pain after surgery.